National Swine Resource and Research Center A&R Adm Sup

Project Summary
Our goal for this Administrative Supplement is to purchase equipment that will replace dated equipment with
new more functional equipment and enhance the utility in phenotyping the models created. The equipment falls
into broad categories that include Surveillance, Animal Welfare, Expanding Capacity, and Leveraging models
currently available in the NSRRC.

Public health relevance
Project Narrative The project describes purchase of equipment, and the use of that equipment to enhance Disease Surveillance, Animal Welfare, Expand Capacity, and Leverage models currently available in the NSRRC. Long-term these purchases will enable further development of the pig as a model to study, understand and treat human diseases.